NONINVASIVE MAGNETIC MEASUREMENT OF CURRENT IN PERIPHERAL NERVE

The magnetic field and electric potential produced by action currents in a human median nerve have been measured in normal volunteers. A mathematical model has been developed, relating the measured magnetic field to the current distribution. The project is aimed at developing a noninvasive technique to monitor peripheral nerve regeneration in patients who have suffered localized nerve damage.